The Safety Integration Stakeholders (SAINTS) program to integrate worker and patient safety in Oregon rural hospitals

PROJECT SUMMARY/ABSTRACT
The COVID-19 pandemic accentuated the inextricable link between worker and patient safety. Yet most
hospitals have separate initiatives for either patient or worker safety. A case in point is safe patient handling
and mobility (SPHM), where most programs are implemented by Employee Health and Safety without
coordination with other quality or patient safety departments. This disconnect is significant because adverse
and costly outcomes such as patient falls or workers’ patient-assist injuries have overlapping risk factors that
must be addressed together. One promising response is through a program that integrates stakeholders,
including influential front-line workers, to address overlapping risk factors for patient falls and patient-assist
injuries. Our preliminary research pre-tested an integrated safety program at a rural hospital in Oregon that
demonstrated 12-month effectiveness in improving leading indicators and reduction of patient-assist injury
rates. The program had four main components: 1) the involvement of patient and worker safety stakeholders;
2) the innovative application of Social Network Analysis (SNA) to identify peer-recognized safety leaders
instead of self- or supervisor-nominated workers who may not have the influence required to effect change; 3)
training stakeholders on safety leadership, and 4) implementation of quality improvement (QI) cycles to reduce
safety barriers. Based on these promising results, we plan to build a new scalable intervention to be tested in a
rigorous multi-hospital trial. The objective of this proposal is to conduct a cluster randomized controlled trial in
six rural hospitals to evaluate the effectiveness and process of a safety program titled Safety Integration
Stakeholders (SAINTS). We will test the central hypothesis that relative to usual practice controls, the three
hospitals randomly assigned to the SAINTS program will have reduced risk factors for patient falls and patient-
assist injuries 12 months after the end of the program. The rationale is that the SAINTS program will positively
impact outcomes by identifying and training key players on strategies to boost environmental, administrative,
and educational precautions relevant to SPHM. We propose two aims: Aim 1: Determine the SAINTS'
effectiveness in reducing overlapping risk factors for patient falls and patient-assist injuries. Effectiveness will
be determined by surveying in-patient unit workers on risk factors for patient-assist injuries and patient falls at
baseline, six months after program initiation, and 12 months after the end of implementation (primary
endpoint). The trial is powered to detect changes in leading indicators, but we will also examine lagging effects
on the incidence rates of patient falls, patient-assist injuries, entries in reporting systems, and staff turnover.
Aim 2: Identify safety precaution measures produced by the SAINTS program. Given the semi-structured
design, we will conduct a multi-method process evaluation to identify the extent to which the program was
delivered as planned and if it led to the adoption of preventative measures.

Public health relevance
NARRATIVE The COVID-19 pandemic stresses the deep interconnection between patient and worker safety, yet most hospitals had separate initiatives for either patient or worker safety. One promising approach to respond to this need is through a program that integrates stakeholders, including influential front-line workers, to address overlapping risk factors for patient falls and patient-assist injuries. Building on a successful pilot program focused on safe patient handling and mobility (SPHM), the objective of this proposal is to conduct a cluster randomized controlled trial in rural hospitals in Oregon to evaluate the effectiveness and process of an integrated SPHM program titled Safety Integration Stakeholders (SAINTS).